Developmental Funds

DEVELOPMENTAL FUNDS - ABSTRACT
Developmental Funds are requested to support five areas of high importance in accordance with the UHCC
strategic plan: Faculty Recruitment, Pilot Projects, and Early Stage Clinical Investigators. The objective of
the University of Hawai‘i’s Cancer Center’s (UHCC) Developmental Funds is to strengthen cancer research
capabilities, foster scientific progress, improve patient outcomes, decrease cancer differences in health
outcomes, and advance our understanding of cancer. These objectives feed directly into UHCC’s mission to
reduce the burden of cancer in the State of Hawai‘i and the US Affiliated Pacific Islands. In alignment with the
UHCC strategic plan, we propose to use Developmental Funds to support three Aims: 1) Identify and recruit
key faculty with the leadership and research vision to expand our programs’ breadth and depth; 2) Identifying
and funding innovative pilot projects among UHCC Members to advance cancer research in key areas; 3)
Encourage next-generation translational scientists and physicians by jump-starting their research pathways..
By supporting these areas, we will strengthen our existing Research Programs and achieve our stated vision to
be a global leader in cancer care, prevention, and education, significantly reducing the cancer burden in
Hawai‘i and the Pacific. The designated Developmental Funds will foster new collaborations, enhance
translational and clinical science capabilities for both CB and PSP Programs, and address the needs of our
faculty members. Effective internal and external advisory processes have been established to guide the
allocation of Developmental Funds. Our successful utilization of prior Developmental Funds is evidence of
UHCC’s ability to leverage funding to make transformative advances in basic, translational, and clinical
research.